Targeting The GLP-1 Receptor As New Chronotherapy Against Nondipping Blood Pressure In Diabetes

ABSTRACT
In healthy individuals, blood pressure (BP) is 10-20% lower during the sleep period than daytime levels.
Chronic disruption in this day-night pattern has shown to be an independent risk factor for type 2 diabetes
(T2DM), atherosclerosis, stroke, kidney disease, retinopathy, and more. These risks increase the less BP dips,
with the most severe phenotype being reverse dipping – a pattern characterized by increased BP during the
sleep period over daytime levels. Vascular complications are invariably associated with T2DM with prevalence
rates of nondipping BP observed as high as 73%. Glucagon-like peptide-1 (GLP-1) receptor agonists (RAs)
have emerged as effective glucose-lowering therapy, with a diverse range of half-lives, for type 2 diabetics. But
because the GLP-1 receptor (GLP-1R) is widespread, GLP-1 RAs have shown to have a multitude of beneficial
effects independent of their glucose-lowering properties. Inhibition of food intake, anti-inflammatory properties,
and reduction in BP are among them. My preliminary data demonstrates a clear restoration in BP's rhythm in a
diabetic mouse model when the short half-life GLP-1 RA, exenatide, is administered at the onset of the light
phase and its rhythm exacerbated when administered at the onset of the dark. Coinciding with this, is a
restoration or worsening in food intake's diurnal rhythm. Currently, FDA guidelines consider exenatide's
administration timing only in the context of glucose-lowering. The goal of this proposal is to investigate if, and
how, restoration of BP rhythm lends to improvement in vascular contractility and structure. Additionally, the
long half-life GLP-1 RA, semaglutide, will be explored on these parameters. Moreover, a novel smooth muscle-
specific GLP-1R knockout mouse model will be generated to determine the GLP-1R's role in vascular smooth
muscle hyper-reactivity, characteristic in type 2 diabetes. I hypothesize that timed administration of GLP-1 RAs
will correct disruptions in circadian rhythm of BP, which will lead to healthier vascular functioning in diabetic
mice. With a rich history in circadian and vascular research, my lab is uniquely positioned to carry out and test
everything proposed. Funding of this proposal will not only provide me with exceptional training in biochemical,
molecular, physiological, and pharmacological experimentation, but also potentially offer a novel
chronotherapeutic approach to improve these, and other GLP-1 RA's, usage in the treatment of T2DM.

Public health relevance
PROJECT NARRATIVE Nondipping blood pressure (BP) describes a dysfunction in BP's natural, healthy day-to-night rhythm and is prevalent in type 2 diabetes (T2DM). GLP-1 receptor agonists (RAs) are effective at lowering blood glucose in T2DM and have also shown to have BP-lowering effects. This proposal seeks to investigate the time-of- administration and half-life differences of GLP-1RAs to correct nondipping BP, thereby improving vascular function and mortality outcomes in T2DM.